PANK Activators for the treatment of pantothenate kinase-associated neurodegeneration

SUMMARY
Pantothenate kinase-associated neurodegeneration, PKAN, is a rare progressive neurodegenerative disorder
associated with iron accumulation in the brain. The disease causes early immobility and often death by early
adulthood. PKAN is caused by mutations in one of four human pantothenate kinase genes, PANK2 gene, which
encodes a mitochondrial pantothenate kinase. Consistent with the clinical presentation of PKAN in humans, cell
biological analyses from patient-derived cells as well as phenotypic characterization of mouse models of PKAN
have demonstrated that the loss of PANK2 activity results in major metabolic, cellular and physiological defects.
We have recently discovered that PKAN disease has the hallmarks of a mitochondrial disorder with large
accumulation of mitophagosomes. This has led us to discover a novel biomarker that could be used to
differentiate between PKAN and normal cells using cell imaging. To date, no specific or established therapy
exists for PKAN with most treatments directed towards managing symptoms and to slow disease progression.
We hypothesize that activation of the human PANK3 (hPANK3) enzyme would result in stimulation of CoA
production in PANK2 mutated cells and would represent an ideal treatment of PKAN. Chemical screening and
subsequent medicinal chemistry optimization (SAR) of the lead chemotype identified 9 human PANK3 activators
(VTAC1-9) that strongly activate hPANK3 with AC50 values in the nM range. These compounds do not affect the
activity of human PANK1 or PANK2, show no toxicity against four human cell lines and one primary human cell,
and have desirable functionality and solubility properties. Pharmacokinetics studies in mice with the early leads
VTAC1 and VTAC2 demonstrated both plasma and brain exposure, excellent t½, and no apparent toxicity.
Together these data indicate that these compounds are ideal candidates for the development of an effective and
safe PKAN therapy. The goal of the proposed research is to conduct detailed characterization of active
VTACs and a library of their analogs to identify late leads that could be advanced towards future clinical
development. Towards this end, we will pursue the following three specific aims. In Aim 1, we will complete
current SAR on this family compounds by characterizing the biochemical activity, selectivity and physico-
chemical properties of an already synthesized 29 analogs and an additional 200 compounds to be evaluated on
an iterative basis. In Aim 2, we will conduct cell-based assays to identify compounds with excellent in vitro
therapeutic index and can restore biological activity in pank2-deficient cells. In Aim 3, we will conduct ADME
and PK analyses and evaluate the in vivo efficacy of VTAC1 and VTAC2 and new leads from Aim 1 in pank2-/-
mice by monitoring important PKAN biological metrics including activation of the CoA metabolic pathway, iron
homeostasis, mitochondrial metabolism, and rescue of PKAN-like phenotypes. The success of these studies will
set the stage for future clinical evaluation of a lead activator of hPANK3 as a possible effective and safe treatment
for PKAN.

Public health relevance
NARRATIVE Pantothenate kinase-associated neurodegeneration (PKAN) is a rare genetic disorder that causes progressive extrapyramidal dysfunction and dementia and characterized by iron deposition in the brain. The disease is caused by autosomal recessive mutations in the PANK2 gene, which encodes the enzyme pantothenate kinase, responsible for the metabolism of vitamin B5 (pantothenate). Herein, we propose biochemical, cell biological and mouse studies to evaluate the efficacy and safety of a novel class of molecules for the treatment of the disease.